The Immunomodulatory Function of Cyclin E1 in Ovarian Cancer and Therapeutic Targeting

A. Project Summary/Abstract
Ovarian cancer is the second most common cause of gynecologic cancer death in women around the world.
High-grade serous ovarian cancer (HGSOC) accounts for more than 70% of all ovarian cancer deaths.
Approximately 50% of HGSOCs harbor alterations in the genes involved in homologous recombination (HR)
DNA repair pathway. These tumors tend to respond well to PARP inhibitors and chemotherapy. CCNE1 (Cyclin
E1) gene amplification and overexpression is frequently found in HR-proficient ovarian cancer and is associated
with primary chemoresistance and poor clinical outcomes. CCNE1 gene amplification is present in 15-20%
ovarian tumors, and overexpression of Cyclin E1 is detected in over 40% of ovarian cancer specimens. Currently,
there are no effective treatment approaches for this type of HGSOC. By using Cyclin E1-overexpressing
syngeneic and humanized ovarian patient-derived xenograft (PDX) models of HGSOC, we will identify novel
therapies for the treatment of HGSOC cancers with amplification or high expression of Cyclin E1.
Our preliminary data suggests that Cyclin E1 downregulates IRF1 and type I interferon (IFN) expression in a
CDK2 kinase-independent manner in ovarian cancer cells. Our preliminary data also reveal that overexpression
of Cyclin E1 in ovarian cancer cells promotes pro-tumor polarization of tumor-associated macrophages (TAMs)
in the tumor microenvironment (TME). Expression of IRF1 and type I IFNs has been implicated in pro-tumor
polarization of TAMs in cancers. We plan to investigate the molecular mechanisms underlying the regulation of
Cyclin E1 on the type I IFN signaling pathway and TAMs in Cyclin E1-amplified/overexpressing HGSOC tumors
and to develop therapeutic approaches for this type of ovarian cancer. We hypothesize that downregulation of
IRF1 and type I IFNs by Cyclin E1 in tumor cells fosters an immunosuppressive TME in HGSOC with Cyclin E1-
amplification/overexpression by promoting pro-tumor macrophage polarization. We also hypothesize that
targeting the conventional tumor cell-intrinsic oncogenic function of Cyclin E1 with CDK2i (CDK2 inhibitors) or
ATRi (Ataxia telangiectasia, and Rad3-related inhibitors), in combination with remodeling the pro-tumor TAMs
that induced by expression of Cyclin E1 in the TME with immunomodulators, such as STING agonists, will
provide promising therapeutics for ovarian cancer patients with Cyclin E1-amplification/overexpression. In Aim
1, we will determine how cyclin E1 regulates IRF1 and type I IFNs in both human and mouse ovarian cancer cell
lines. In Aim 2, we will determine how the Cyclin E1-regulated type I IFN signaling pathway promotes pro-tumor
polarization of TAMs and immunosuppression in the TME of HGSOC tumors with Cyclin E1-
amplification/overexpression both in vitro and in vivo. In Aim 3, based on our recent findings that STING agonism
activates type I IFN signaling pathway and repolarizes pro-tumor macrophages to an anti-tumor status, we will
assess the therapeutic efficacy and toxicity of STING agonists in combination with CDK2i or ATRi, in both
syngeneic mouse models and humanized PDX models.

Public health relevance
Project Narrative The proposed research is designed to investigate how Cyclin E1 regulates the IRF1 and type I interferon signaling pathway in ovarian tumor cells and how Cyclin E1 promotes pro-tumor polarization of macrophages and immunosuppression in the tumor microenvironment (TME) of ovarian cancer with Cyclin E1- amplification/overexpression. We will also develop potential therapeutic approaches for ovarian cancer with Cyclin E1-amplification/overexpression by targeting both tumor cell intrinsic oncogenic activity of Cyclin E1, as well as the immunosuppressive TME induced by Cyclin E1 overexpression. Preclinical evaluation of STING agonists in combination with CDK2 or ATR inhibitors in syngeneic and humanized mouse models will provide potentially effective treatment strategies for patients with Cyclin E1-amplified/overexpressing ovarian cancer. 1